ABCD-USA Consortium: Data Analysis, Informatics and Resource Center

This Administrative Supplement to the ABCD-USA Consortium: Data Analysis, Informatics and
Resource Center (DAIRC) supports the ongoing efforts of the DAIRC to develop and maintain the
new data release infrastructure and associated workflows for data releases. The infrastructure
which will be launched this grant year, along with the release of the 6.0 ABCD Data, is planned
to be used for all future data releases. These supplemental activities will allow for broader use of
ABCD data, including to better ascertain the use of opioids and fentanyl and their impact on
adolescent development and the developing brain. By following more than 10,000 children as
they go through adolescence, the ABCD Study is well-positioned to explore how their many
experiences including substance initiation and use shape their social, emotional, intellectual, and
physical growth. These additional activities are important because the data sharing
system/solution needs to be optimized for large datasets (including neuroimaging, genomics) and
provide scalable data ingestion, integrated data analytics, and a customized user experience.
A central component of the new data release infrastructure is the reimplementation and extension
of the Data Exploration and Analysis Portal (DEAP version 2.0), which will feature extended
functionality for data download, exploration, statistical analysis, and advanced visualization. The
DAIRC is leading the development of DEAP 2.0 and supporting efforts, including the development
of backend components, databases, storage infrastructure, and computing infrastructure. This
support further funds the DAIRC’s development of more streamlined and standardized internal
data management processes which are essential to prepare the tabulated data, file-based data,
and metadata for releases on an ongoing basis. As part of this, the DAIRC are migrating to a new
database system, and working with contractors to set up and maintain security measures to
uphold NIH security requirements. In order to maximize the utility of this improved infrastructure
the ABCD data is being re-curated and user-resources are being expanded to better support data
users.

Public health relevance
This supplement to the ABCD-USA Consortium: Data Analysis and Informatics Resource Center (DAIRC) funds ongoing efforts to develop a new infrastructure for data releases for the Adolescent Brain Cognitive Development (ABCD) Study. The goal is to have the infrastructure set up in time for the 6.0 data release scheduled for Fall 2024 and to use this infrastructure for all data releases going forward.